Training Core

Training Core Abstract
The broad goal of KUH-ART is to prepare our trainees to become leaders in cutting edge research in the
nephrology, urology and hematology areas. Our trainees will have either a clinical background or basic
science background combined with an interest in solving medically relevant questions in the KUH area. UCLA
KUH-ART will consolidate existing fragmented research training programs under one umbrella and create a
larger regional entity where trainees are part of an interactive cohort. The Specific Aims of the KUH-ART are:
1. Guide trainees in developing a strong foundation of knowledge in biological and health sciences relating to
different aspects of kidney, benign urologic and benign hematologic diseases.
2. Provide individualized hands-on mentored research training in each trainee’s focus area of basic,
translational, clinical or computational research.
3. Develop trainees’ scientific writing and communication skills for presentations, publications, and grants (see
Professional Development Core).
4. Maintain an interactive and supportive academic environment that promotes the development of team
research skills and collaborative experience needed for successful, independent scientific careers as
members and leaders of interdisciplinary teams.
5. Develop a KUH community through a versatile instructional and mentoring platform geared to the trainees,
mentors, the KUH scientific community and other research stakeholders at UCLA and nation-wide (see
Networking Core).
6. Devise and implement comprehensive tracking and ongoing evaluation in multiple areas of the program by
structured feedback from trainees, mentors, Internal and External Advisory Boards and NIDDK to identify
weaknesses and institute continuous quality improvement.
We aim to prepare outstanding pre- and postdoctoral scholars for research careers in benign KUH and allied
disciplines, promote multidisciplinary team research, and expand research workforce with both physicians and
non-clinician investigators pursuing or newly attracted to KUH research. Our goal is to attract an outstanding
group of pre- and postdoctoral applicants who seek a cross-training experience across the research spectrum
from basic sciences and translational medicine to health services and informatics. We have carefully selected
56 outstanding mentors who have a record of commitment to biomedical research training in the KUH and related
areas. The proposed new UCLA KUH-ART integrates and mutually potentiates the previously fragmented
research training and career development enterprise at UCLA and affiliated institutions. Ultimately, our graduates
will accelerate the volume, pace, and translation into practice of scientific discoveries and innovations that
improve the care and outcomes of patients across the lifespan, from children to the elderly.